RHVEGH IN UNDERPERFUSED MYOCARDIUM

Study of multiple doses of intravenous RHVEGH in subjects with stable exertional angina with areas of viable but underperfused mycardium who are not optimal candidates for surgical or percutaneous revascularization.